Comprehensive, Flexible and FAIR Tools for the HuBMAP HIVE

The Human BioMolecular Atlas Program (HuBMAP) will redefine our understanding of the human body by recovering multi-scale tissue organization -- anatomical, histological, and molecular, at unprecedented resolution, through computational integration of diverse experimental measurements. Our main focus in Year 2 would be gearing up for the initial HuBMAP data release expected by the end of 2020. As part of this we propose to develop and implement several computational tools and pipelines to support the various types of data that are expected to be collected including sequencing and imaging data. We would determine and develop analysis tools for the different levels of abstractions required for each data type and for the integration of several different data types. We would continue to lead several HuBMAP working groups and to interface with other international efforts to make sure that work is not duplicated while also ensuring that all tools required for HuBMAP are in available.

Public health relevance
The Human BioMolecular Atlas Program (HuBMAP) will redefine our understanding of the human body by recovering multi‐scale tissue organization ‐‐ anatomical, histological, and molecular, at unprecedented resolution, through computational integration of diverse experimental measurements. To ensure that the data is accurate, accessible and easy to use we will develop computational tools and pipelines for data analysis, processing and integration. Linking these tools to data deposited by the Tissue Mapping Centers and to the HIVE data portal will enable both internal and external users to interact with the collected data, download it and utilize it for ongoing and future studies.